Evaluation of High-throughput Extracellular Vesicle Loading Platform for Therapeutic Genome Editing INDs

ABSTRACT
Extracellular vesicles (EVs) have been an emerging approach for delivering genome editing therapeutics. Due
to their superior biocompatibility and low immunogenicity compared to lipid nanoparticles (LNPs) and viral
vectors, EVs have been in increased needs for developing gene therapy. Despite great promise for clinical
translation, standardization of EV isolation and cargo loading at the scale has been challenging, which
substantially hindered the clinical translation of EV-based genome editing technologies. Transfection of EVs for
genome editor loading is a key step in functional therapeutic development. However, current transfection
approaches suffer from low transfection rate, and low scalability and volume processing throughput. In this
project, we aim to optimize and evaluate our recently developed high-throughput EV loading platform with
rigorous quality characterization on EVs and genome editor payload, which will provide essential data on CMC,
Critical Quality Attributes (CQAs), and toxicology of EV based CRISPR gene therapy for IND submission. The
Aim 1 will focus on optimization of high-throughput EV loading platform (µDES) with genome editors for GMP
manufacturing. The Aim 2 will optimize ExoQuality approach as the IND-enabling assessment to establish the
Critical Quality Attributes (CQAs) of EV based genome editing therapeutic products. The Aim 3 will focus on the
pharmacological and toxicological evaluation on developed CRISPR RNP EVs with modality in treating hearing
loss for IND submission. The project will lead to the scalable GMP manufacturing procedures for EV based
genome editing products and establish acceptable CQA criteria and CMC data to accelerate EV based genome
editing product for IND submissions. The outcome will significantly impact on accelerating the translation of
novel, safe, and effective therapeutic genome editing strategies to first-in-human clinical trials.

Public health relevance
PROJECT NARRATIVE This project aims to optimize and evaluate the high-throughput EV loading platform with rigorous quality characterization on EVs and genome editor payload, which will provide essential data on CMC, Critical Quality Attributes (CQAs), and toxicology of EV based CRISPR gene therapy for IND submission. This project will set as the first extracellular vesicle based enabling gene therapy approach to advance disease treatment.